Prognostic Implications of Home-Based Blood Pressure Monitoring in Older Adults

Hypertension affects over 85% of adults over 75 years of age and represents one of the few modifiable risk
factors to prevent dementia and cardiovascular disease (CVD) events in older adults. However, current practice
guidelines for hypertension screening and treatment focus heavily on blood pressure (BP) measurements
obtained in clinic settings. This reliance on brick-and-mortar offices for BP measurement represents a significant
barrier for older adults, who often depend on others for transportation and who are at increased risk of severe
morbidity from the current COVID-19 pandemic. Home BP monitoring (HBPM) has shown incredible promise for
more effective and timely BP treatment and control. Furthermore, the current pandemic has catalyzed
widespread adoption of HBPM for hypertension screening and management. However, evidence for this practice
is severely lacking in older adults. In fact, there are virtually no HBPM cohort studies in elderly populations in the
United States. This is particularly concerning as the discordance between clinic and home BP increases with
age, making older adults especially susceptible to harms from either overly aggressive or delayed BP treatment.
In this proposed study, we apply our unique expertise with HBPM and 24-hour ambulatory blood pressure
monitoring to one of the most long-standing and well-respected American cohorts of community-dwelling adults,
the Atherosclerosis Risk in Communities Study (ARIC). While ARIC already rigorously measures BP in the clinic
setting via automated devices, our proposal will additionally assess 8 days of HBPM and 24 hours of ambulatory
BP (once every 20 minutes) in 2,142 racially diverse adults over age 80 years, establishing possibly the largest
prospective study of home, ambulatory, and clinic-based BP measurement among older adults in the world. This
proposal is designed to directly inform clinical practice with HBPM by characterizing its measurement
performance (bias and variance), predictiveness with respect to key long-term events (dementia and CVD), and
interpretation (i.e. what a home BP measure equals in terms of BP measured by ABPM or in clinic).
The accomplishment of this proposal will address critical gaps in knowledge related to an increasingly utilized
form of BP measurement, improving access to timely hypertension care by establishing an efficient protocol for
precise BP measurement at home. Moreover, by investing in the digital monitoring platform of the ARIC study,
this proposal will lay the foundation for remote collection of a wide range of detailed, longitudinal, biosensor data
that can be leveraged by many investigators through subsequent ARIC proposals in years to come.
With current trends in BP control worsening among older adults in the United States, there has never been a
greater need for research on innovative technologies to improve access to high quality BP measurement.
Ultimately, our proposal directly answers the call by NHLBI's 2017 expert panel on BP measurement for high
impact research that determines “the role of ABPM and HBPM in the diagnosis…of hypertension” and “the
optimal protocol for using HBPM…to diagnose and assess…hypertension.”

Public health relevance
High blood pressure is the most prevalent modifiable risk factor for dementia and cardiovascular disease among older adults in the United States; however, clinic-based blood pressure measurement is inaccessible to many older adults, especially in the COVID-19 era, often delaying hypertension diagnosis and treatment. While home- based blood pressure measures show promise for overcoming access barriers and promoting more timely treatment, there is a dearth of evidence informing the clinical interpretation of these measurements inolder adults in the United States, a population characterized by high blood pressure variability and discordance from clinic- based blood pressure. Our proposal will perform home blood pressure monitoring and 24-hour ambulatory blood pressure monitoring assessments in over 2,100 community-dwelling adults, aged 80-100 years, establishing the measurement performance, prognostic utility (for dementia and cardiovascular disease), and clinical interpretation of home-based blood pressure measurements in this vulnerable population in the United States.